Animal Models of Suicide Relevant Intermediate Behavioral, Neurobiological and M

The experience of childhood adversity in the form of neglect/abuse is a major risk factor for future suicidal behavior perhaps via long-term changes in molecular and neurobiological substrates of anxiety, depression, and impulsivity/aggression. The mechanistic links between childhood adversity, molecular/neurobiological pathways, and suicide risk have yet to be established. We propose to investigate key hypotheses regarding: 1) whether childhood adversity is a causal antecedent to suicide behavioral, neurobiological, and molecular phenotypes; 2) the time course of adversity-induced effects on gene expression and epigenetic variation within target gene clusters: 3) the degree of concordance between peripheral cell epigenetic marks and those present in the brain; and 4) explore reversal of such effects by

Public health relevance
RELEVANCE (See instructions): This project seeks mechanistic insight into the causal relationships between early life adversity, epigenetic effects, gene expression and biological and behavioral phenotypes associated with suicidal behavior. The knowledge gained through our research will contribute to the identification of at risk individuals and provide novel approaches for intervention/treatment of the suicide behavior diathesis.